Characterization and Early Assays Development in FOXG1 Deficient Neurons

PROJECT SUMMARY
FOXG1 syndrome is a rare neurological disorder that often causes severe intellectual disability,
microcephaly and neurological symptoms including hypotonia, seizures, and stereotypic
movements. FOXG1 syndrome is caused by heterozygous mutation or deletion of the forkhead
box 1 protein (FOXG1), a transcription factor that controls expression of key cortical development
proteins. FOXG1 is specifically important for telencephalon neural progenitor cell (NPC)
proliferation and differentiation to GABAergic interneurons. We have prioritized FOXG1 syndrome
based on a framework we developed to evaluate monogenetic neurodevelopmental disorders for
therapeutic development based on generic, preclinical validation, clinical and ethical
considerations. We have also created three pluripotent stem cell (PSC) lines from FOXG1
syndrome patients and used CRISPR/Cas9 gene editing to create isogenic control lines. We
hypothesize that a drug-like small molecule that increases FOXG1 expression in patients during
early postnatal development would improve symptoms in these individuals. In the proposed
research, we will use FOXG1 PSC lines to create an endogenous locus gene reporter line by
using CRISPR/Cas9 to insert a HaloTag reporter protein at the C-terminus of the FOXG1 gene.
A method will be developed whereby these modified FOXG1 PSCs with be differentiated to
cortical neural progenitor cells (NPCs) and treated with HaloTag ligand tethered dyes to measure
accurately measure FOXG1 expression. The primary goal of this project will be to demonstrate
that this FOXG1 reporter system is suitable for screening small molecules for their ability to
increase FOXG1 expression.

Public health relevance
PROJECT NARRATIVE FOXG1 syndrome is a rare neurological disorder that often causes severe intellectual disability and other serious symptoms. Studying this disorder and ultimately finding a treatment would change the lives of patients and could help us understand other severe neurological disorders. This project aims to develop a method that will be used to discover drugs for the treatment of FOXG1 syndrome.